Career Enhancement Program

PROJECT SUMMARY
The goal of the Lymphoma SPORE’s Career Enhancement Program is to provide support for young
investigators pursuing careers in translational lymphoma research as well as for established investigators
who wish to refocus their work on lymphoma. The program is led by Drs. Helen Heslop, Martha Mims and Sid
Ganguly and will be co-ordinated by the Administrative Core with oversight from the Executive Committee
and Internal and External Advisory Boards. Continually improved throughout the previous funding cycles, our
established Career Enhancement Program has well-defined processes and for candidate recruitment. We will
continue to collaborate with the Baylor Office of Diveristy, Equity, and Inclusion to devote significant effort to
recruit women and minorities to our program and the field of lymphoma research — an initiative that has been
successful in the past funding periods when 53% of trainees were female and 37% were under-represented
minorities (Hispanic or African American). Both MD and PhD trainees will be able to take advantage of courses
available through the Clinical Scientist Training Program at Baylor College of Medicine and will have a strong
group of mentors with broad translational expertise. We have developed mentoring strategies focued on the
unique challenges of moving cell and gene therapies from the bench-to-the-bedside, as well as the dynamics
of team science, that enhance the overall training program. Specifically, these strategies include providing
trainees with multiple mentors that possess complementary skills, individualized training plans, and multiple
opportunities to participate in learning courses and attend lectures relevant to the field. Additionally, trainees
have access to the SPORE cores (Clinical Research and Biostatistics, Cell Processing and Vector Production,
Biospecimen and Pathology) with unique expertise in cell and gene therapy and clinical research. In the last
14 years,19 awardees have been selected for this Program, seven of whom are now incorporated into the
SPORE program with 4 as project leaders in the current renewal . This Program will therefore ensure that the
SPORE will continue to train promising investigators who will contribute to translational lymphoma research
into the future.

Public health relevance
PROJECT NARRATIVE The goal of this program is to provide training in translational research in lymphoma for a diverse group of young investigators or established investigators who wish to refocus their career on lymphoma. This Lymphoma SPORE’s Career Enhancement Program aims to increase the number of promising investigators working in this field in the future through tailored learning programs, expert mentorship, and individualized training in the translation of cell and gene therapies for lymphoma.